Pathways Affecting Trophoblast Development

PROJECT SUMMARY/ABSTRACT
Trophoblast cell derivatives of the early embryo contribute to restructuring the uterine environment, an event
required for the establishment of a successful pregnancy. The human and rat each possess a uterine-
trophoblast interface that is characterized by deep intrauterine infiltration of trophoblast cells, which contributes
to dynamic changes in uterine immune cell, endothelial cell, smooth muscle cell, and stromal cell constituents.
This important developmental process is directed by specialized trophoblast cells possessing invasive
properties referred extravillous trophoblast (EVT) in the human or by the generic term invasive trophoblast cells
in other species, including the rat. Differentiation into these specialized trophoblast cell types requires
suppression of pathways essential for maintaining the trophoblast cell stem state and activation of the
invasive/EVT cell differentiation program. We hypothesize that repression of the trophoblast cell stem state is
an event essential for the establishment of pregnancy. In this project, we investigate roles for activin-follistatin
like 3 and WNT-WNT antagonist regulatory networks controlling development of the invasive/EVT cell lineage.
Roles for the activin-follistatin like 3 and WNT-WNT antagonist regulatory networks are the focus of Aims Nos.
1 and 2, respectively. In Aim No. 3, we examine FSTL3 and the WNT antagonist, NOTUM, in patient-specific
human trophoblast stem cells. Experimentation includes genome-wide analyses of the transcriptome and the
chromatin landscape. Execution of this research project will facilitate elucidation of elements of the regulation
of the invasive/EVT cell lineage and will create a platform for understanding the pathogenesis of early
pregnancy loss.

Public health relevance
PROJECT NARRATIVE (RELEVANCE STATEMENT) Central to the etiology of disease processes leading to early pregnancy loss, preeclampsia, intrauterine growth restriction, placentae abruptio, and pre-term birth is abnormal development of the uterine-placental interface. Morphogenesis of the uterine-placental interface depends on differentiation and actions of the invasive/extravillous trophoblast cell lineage. Elucidation of mechanisms controlling invasive/extravillous trophoblast cell differentiation and its involvement in the development of the uterine-trophoblast cell interface will lead to the discovery of diagnostics for early detection of failures in the establishment of pregnancy and regulatory events that can be targeted for therapeutic intervention.